Causes and consequences of interpersonal microbial variation

Summary
The purpose of this proposal is to provide equipment support to our currently funded NIGMS research
project (2R35GM118159-08). Despite the possibility that the gut microbiome may represent a critical
and readily modifiable component of human biology, the contribution of the gut microbiota to health,
disease risk, and response to therapy remains largely undefined. The overall goal of the parent grant
is to understand the principles, mechanisms, and processes that shape the interaction between gut
microbial communities and their hosts. Our strategy is to combine anaerobic microbial genetics and
high-throughput mass spectrometry with gnotobiotic (germfree and ex-germfree) mouse models to
dissect these interactions. The central analytical approach in these studies is mass spectrometry,
which we use to precisely measure microbial metabolism of dietary and other compounds and identify
metabolites produced as a result of these activities. Although we have made significant progress in
the project, the main limiting factor is the restricted access to time on a mass spectrometer. For this
reason, we request funds to partially support the purchase of a mass spectrometer to support this
project. The purchase cost, site preparation, installation, and maintenance of this instrument will also
be significantly supported by the university.

Public health relevance
Project Narrative The parent project aims to understand how diet and interbacterial interactions shape the microbiome at a molecular level. We rely on an aging mass spectrometer for most of these studies, and insufficient access to instrument time is the major limiting factor for our work. We request funds that will be combined with university contributions to purchase a mass spectrometer that will allow us to significantly expand our research.